The mosquito salivary protein AgBR1 as vaccine candidate against Chikungunya

PROJECT SUMMARY
Chikungunya is an arboviral disease transmitted to humans by infected mosquitoes, primarily
the Aedes aegypti and Aedes albopictus species. The virus responsible for the disease is the
chikungunya virus (CHIKV), a member of the Togaviridae family. First identified in Tanzania in
1952, chikungunya has since been reported in over 60 countries in Asia, Africa, Europe, and the
Americas. The symptoms of chikungunya typically include febrile illness, joint pain, nausea,
fatigue, and rash. While the fever usually subsides within a week and the disease is rarely fatal,
joint pain can be severe and debilitating, often lasting for weeks or years.
There is no specific antiviral treatment for chikungunya; care is based on relieving symptoms,
such as with anti-pyretics, optimal analgesics, and fluids. Prevention relies on avoiding mosquito
bites using repellents, wearing long sleeves and trousers, and eliminating standing water where
mosquitoes breed. Vaccine against CHIKV is urgently needed. Only one vaccine has achieved
approval, Valneva's IxchiqTM, which is based on a live attenuated CHIKV. This vaccine undergone
an accelerated regulatory approval by FDA with limited human clinical efficacy study.
Many mosquito salivary proteins were shown to have pro-viral activity and can augment virus
transmission during blood feeding. We have found a mosquito salivary protein, AgBR1, that can
enhance viral transmission and shown that immunization with AgBR1 is protective against several
flaviviruses. Specifically, vaccination of mice with recombinant AgBR1 is protective against Zika,
and passive transfer of AgBR1 antiserum is protective against West Nile disease.
In this proposal, we seek to confirm that AgBR1 vaccine is also protective against Aedes-
transmitted arbovirus of the alphavirus genera, the CHIKV. We will perform comparative
evaluation of different AgBR1 formulation, either recombinant protein or mRNA-LNP vaccine, in
preventing mosquito-borne CHIKV infection in mice. To ascertain the effectiveness of our vaccine
against CHIKV transmission, we will run our test on two murine model of CHIKV infection – (1) an
acute lethal infection model of immunocompromised mouse to see protective effect of the vaccine
against lethal infection, and (2) adult immunocompetent mice to see protective effect of the
vaccine against disease morbidity such as joint pain and arthritis. Our ultimate goal is to generate
a universal vaccine against several mosquito-borne diseases.

Public health relevance
PROJECT NARRATIVE Chikungunya is a disease transmitted by Aedes mosquitoes that can cause severe and prolonged morbidity. We have found a mosquito salivary protein, AgBR1, that can be used as a vaccine and protects against Aedes mosquito-borne flavivirus infection (ZIKV and WNV) in mice. The goal of this project is to test AgBR1 as a vaccine against another Aedes-transmitted virus -- Chikungunya virus (CHIKV).